Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT
Holden Comprehensive Cancer Center (HCCC) Director, George Weiner, MD is responsible for overseeing all
aspects of the HCCC including appointment of other senior leaders, setting the overarching vision for the
cancer center and implementing that vision. He is assisted by Michael Henry, PhD who serves as Deputy
Director and five Associate Directors (ADs). Gail Bishop, PhD is AD for Basic Research and also oversees the
basic research cores. Mohammed Milhem, MBBS is AD for Clinical Research. Elizabeth Chrischilles, PhD is
AD for Population Science and Community Engagement. Jon Houtman, PhD is AD for Career Enhancement.
Tina Devery is AD for Administration. Invaluable advice is provided to the HCCC leadership team during
annual meetings of the HCCC External Advisory Board that has been expanded since the last review.
Community perspective is provided by quarterly meetings with the Community Advisory Board. Dr. Weiner
chairs the University of Iowa (UI) Health Care Cancer Strategic Investment Committee that serves a role
similar to an internal advisory board and provides input on use of recently designated institutional resources
targeted towards support of new strategic cancer research initiatives. Planning and Evaluation efforts of the
HCCC over the prior funding period include development of a comprehensive strategic plan that is reviewed on
an annual basis to identify top priorities which then serve as the foundation for strengthening current, and
advancing new, initiatives. Over the prior funding period, the HCCC used P30 funds, institutional resources,
philanthropy and cancer strategic investment funding to pursue the goals outlined in its strategic plan. The
HCCC is continuing to implement these concepts while engaging in ongoing planning and evaluation efforts
with its members to identify and pursue future opportunities with a particular focus on the needs of the people
of Iowa.

Public health relevance
PROJECT NARRATIVE Not applicable